Relating impacts of antibiotics on the gut metabolome and microbiome to host physiology and weight.

PROJECT SUMMARY
In the US, the obesity crisis is severe-approximately 40% of American adults and 18.5% of American children
are clinically obese. Robust evidence suggests that antibiotic overuse may be one contributing factor. The human
gut microbiome is a key determinant of health and one crucial function of this community is to regulate host
metabolism by fermenting host-indigestible dietary components. A significant body of work also indicates that in
both humans and animals, antibiotic use- and especially the use of penicillins and other ~-lactams- is strongly
associated with obesity. The mechanism of this antibiotic-associated weight gain is not fully understood, although
many theories exist, ranging from the induction of systemic inflammation to the reduction of pathogen burden.
Understanding how antibiotic-induced perturbations of the microbiome lead to complications such as obesity is
an essential step towards alleviating this problem. The proposed work will contribute to this goal by defining
the impacts of antibiotics on the metabolic environment of the murine gut, host metabolite availability,
and weight gain. Antibiotics can disrupt the microbiome, but what is less appreciated is that this perturbation is
associated with a disruption of the metabolic capacity of gut bacteria and a concomitant perturbation of the gut
metabolome. The Belenky Lab has defined the impacts of several clinically-relevant antibiotics on the
composition and transcriptional response of the murine microbiome. This previous work identified that antibiotics,
specifically amoxicillin, change the composition, transcriptional activity, and the metabolome of the murine cecal
microbiome. The resulting microbial community is metabolically deficient, enriched for Bacteroidetes, and devoid
of Firmicutes. These changes are associated with reduced cecal glucose, reduced butyrate, elevated blood
glucose, systemic inflammation, and weight gain. The core hypothesis of this work is that ~lactam antibiotics
contribute to inflammation and obesity by eliminating critical bacteria in the Firmicutes phylum, subsequently
inducing metabolic dysfunction. The resulting metabolically-deficient gut microbiome is unable to provide critical
nutrients and signaling molecules to reduce inflammation and regulate host metabolism. This hypothesis will be
tested in the following three aims: Aim 1 - Determine the impact of clinically-relevant antibiotics on the
metabolome and taxonomic composition of the murine gut, host physiology, and weight gain. Aim 2 - Utilize
microbial consortia to determine if microbial composition associated with antibiotic therapy is linked to the
detected metabolite shifts and host impacts. Aim 3 - Microbiome restoration and diet modulation to reduce
antibiotic-induced perturbations of the gut metabolome and weight gain. The insight gained from this work will
help to identify methodologies that reduce antibiotic-mediated microbiome disruption and may help to combat
the obesity crisis. Antibiotics have been miracle drugs, but now that we understand the significant cost to
microbiome function, we must find better ways to use them.

Public health relevance
NARRATIVE The proposed research is highly relevant to public health because defining how antibiotic-mediated microbiome disruption contributes to complications such as obesity and diabetes may, in the long run, identify ways to alleviate these conditions for millions of Americans. This work will define the impacts of antibiotics on the metabolic environment of the murine gut, host metabolite availability and weight gain. In addition to generating fundamental scientific discoveries, this research will also fulfill NIH goals by generating a mechanistic perspective on how antibiotics contribute to diabetes, digestive diseases, nutritional disorders, and obesity.